Preclinical assessment of an ABCA1 agonist as a novel therapeutic for AD

DESCRIPTION (provided by applicant): APOE4 is the greatest genetic risk factor for sporadic Alzheimer's disease (AD), increasing risk up to 15-fold compared to APOE3. As APOE4 carriers can respond anomalously in clinical trials, sometimes negatively, there is a critical lack of therapeutics targeting mechanistic pathways of APOE4-induced AD risk. Genetic evidence supports the role of amyloid-ß peptide (Aß), particularly Aß42, as a causative agent in AD, with soluble oligomeric aggregates (oAß) recognized as the likely proximal neurotoxins. As congruent lines of evidence indicate that apolipoprotein E (apoE) isoform-specific modulation of soluble Aß levels may impart APOE4-induced AD risk, our therapeutic goal is to develop apoE-based approaches to reduce oAß levels. Enabled by the development of the novel ELISAs and the new EFAD mouse model (overexpressing Aß42 and expressing human APOE), we have dissected potential pathways underlying the correlation between apoE4 and increased levels of soluble Aß. Our data demonstrate that compared to apoE3, lipoprotein- association/lipidation of apoE4 is reduced, resulting in lower levels of apoE4/Aß complex and higher levels of soluble oAß, compromising synaptic viability. ABCA1 is a promising therapeutic target for testing this hypothesis because ABCA1 is a major transporter of lipid to apoE-containing lipoproteins in the CNS. Using EFAD mice, we recently demonstrated that 1-week treatment with RXR agonists increased ABCA1 levels, apoE4 lipidation, and soluble apoE4/Aß complex levels, while lowering soluble Aß levels and increasing synaptic protein levels. However, in brain regions with low Aß pathology at time of treatment (both E3FAD and E4FAD mice), no beneficial effects were observed and levels of soluble Aß were actually increased. While these data provide target validation for ABCA1, the detrimental off-target effects, attributed to severe hepatomegaly, limit RXR agonist utility in long-term treatment protocols. Artery Therapeutics developed novel ABCA1 agonists, including CogPep B, for the treatment of peripheral cardiovascular disease. CogPep B demonstrates high potency for increasing the activity and levels of ABCA1 in vitro, has a high maximal tolerated dose in vivo and is brain penetrant with concentrations 2-6-fold above the in vitro KM at a dose lower than that proposed herein. In addition, preliminary data demonstrate that CogPeP B increases synaptic protein levels and improves memory in APOE4-targeted replacement (TR) mice compared to APOE3-TR. For the first time, this proposal will assess the CNS effects of CogPep B in treatment (Aim 1) and prevention (Aim 2) protocols in male and female EFAD mice. To meet the ambitious goal set by the Department of Health to prevent or effectively treat of AD by 2025 requires novel therapeutic candidates to target mechanism(s) of APOE4-induced AD risk. This R21 tests such a therapeutic through the preclinical repurposing of CogPep B in the AD-relevant EFAD mice. From a drug discovery standpoint, the repurposing of CogPep B will facilitate successful translation to clinical trials, n alternative safer than current nuclear receptor agonists.

Public health relevance
PUBLIC HEALTH RELEVANCE: Alzheimer's disease (AD) is the leading cause of dementia in the elderly and a rapidly growing epidemic in the United States that currently costs $100 BILLION annually for the care for AD patients (estimated by the National Institute of Aging). APOE4 is the greatest genetic risk factor for AD, and our data using novel protocols and an innovative mouse model has identified a therapeutic pathway of APOE4-induced AD risk. This proposal will pre-clinically repurpose a novel compound developed for cardiovascular disease that targets the novel AD therapeutic pathway we have identified, and therefore, if successful, will accelerate translation to clinical trials.